D1 and D2 Dopaminoceptive Ensembles in Limbic Brain Regions in Drug Addiction

SUMMARY
This R01 grant focused historically on neurotrophic mechanisms in the long-term actions of stimulant and
opioid drugs of abuse on the brain’s reward circuitry, especially the nucleus accumbens (NAc). This effort
contributed to appreciating the distinct roles played by NAc medium spiny neurons (MSNs) that express either
the D1 or D2 dopamine receptor in addiction-related molecular, cellular, circuit, and behavioral abnormalities.
In recent years, our work has evolved still further to focus on subpopulations of these NAc D1 and D2 MSNs –
so-called “ensembles” – which are activated by acute vs. chronic drug exposure. In parallel, we have also
begun to characterize neuronal ensembles in key limbic brain regions that provide glutamatergic inputs to the
NAc. Dopaminoceptive neurons in these other regions are also subdivided into mostly non-overlapping
populations of D1- and D2-expressing neurons. The objective of this competitive renewal application is to
extend our in-depth characterization of drug-activated neuronal ensembles – both in the NAc and in key input
regions – and of prominent drug-induced adaptations in those ensemble neurons that mediate aspects of
addiction-like syndromes in mouse models. Aim 1 focuses on the NAc, where we will continue to use Arc-
CreERT2 mice to tag cells activated in response to one stimulus (e.g., first or last cocaine or opioid exposure)
and track how those cells respond over time during the course of drug self-administration and relapse. We
have robust preliminary data that distinct ARC ensemble cells are recruited by initial vs. repeated drug
exposure and serve different (in some cases opposite) roles in controlling behavioral responses to the drugs.
Interestingly, both the initial and repeated ensembles are composed of mixtures of D1 and D2 MSNs – which
display unique transcriptional patterns compared to non-ensemble D1 and D2 MSNs, which underscores the
importance of moving beyond the simplified dichotomy of characterizing D1 vs. D2 NAc MSNs per se. Studies
with Arc-CreERT2 mice will be complemented by single nucleus RNA-sequencing (snRNAseq) which has
demonstrated much larger ensembles of NAc MSNs that are affected by initial and repeated drug exposure: in
other words, as seen in other brain regions in the learning and memory field as well, ensembles defined by Arc
or any other immediate early gene (e.g., Fos) represent a smaller subset of a larger population of neurons
involved, which can be captured uniquely by use of snRNAseq. As we make progress with the NAc, we will
focus in Aim 2 on equivalent studies of key input regions to the NAc where we have also defined ensembles,
composed of mixtures of D1 and D2 dopaminoceptive neurons, that are activated in response to cocaine or
opioid exposure. We already have considerable preliminary data for such drug-activated ensembles in ventral
hippocampus and the paraventricular nucleus of the thalamus. Together, this work will contribute to an
improved understanding of the biological basis of drug addiction and provide new pathways for identifying
molecular and cellular targets suitable for future therapeutic discovery efforts.

Public health relevance
PROJECTIVE NARRATIVE The objective of this grant is to identify and study the subsets of neurons within the brain's reward circuitry that are activated by initial and repeated exposure to stimulant or opioid drugs of abuse and to characterize their contribution to addiction-related behavioral abnormalities in rodent models. These studies will provide new information concerning how drugs of abuse cause a state of addiction as well as identify novel leads toward the development of improved diagnostic tests and treatments.